Dissecting Neuroglial Innate Immunity in vivo against Polyomavirus CNS Infection

PRORJECT ABSTRACT:
JC Polyomavirus (JCPyV) is a ubiquitous asymptomatic virus that infects up to 90% of humans. In
immunocompromised individuals, JCPyV can cause progressive multifocal leukoencephalopathy (PML), an
often-lethal demyelinating neurodegenerative disease. Because polyomaviruses (PyV) are species-specific,
mechanisms of PML pathogenesis are incompletely understood. The Lukacher group studies Mouse
Polyomavirus (MuPyV), a natural murine virus, to define virologic and immunologic factors involved in PyV
CNS infection and disease. Published work from the Lukacher group has shown that Type I Interferons (IFNs)
directly inhibit MuPyV replication and are necessary to mitigate MuPyV encephalitis. The pathway(s) of Type I
IFN induction during PyV infection in vivo is unknown. In vitro, cyclic GMP-AMP Synthase (cGAS) and
Stimulator of IFN Genes (STING) have been implicated in limiting viral infections by a number of viruses with
double-stranded (ds) genomes, including JCPyV and MuPyV. Our preliminary data using STING-/- cells
confirms the importance of STING in inducing Type I IFN upon MuPyV infection in tissue culture. In this way,
STING is the central adapter protein responsible for the first wave of Type I IFNs. Signal Transducer and
Activator of Transcription (STAT) 1 is a downstream target of Type I IFNs. Signaling via STAT1 potently
inhibits MuPyV replication. How STAT1 acts as a mediator of antiviral activity in MuPyV infected cells in vivo is
unknown. The goal of this proposal is to determine whether cGAS-STING (Aim 1) and/or STAT1 (Aim 2)
act in MuPyV-infected neuroglia in vivo to promote the antiviral Type I IFN axis and control virus-
induced neurovirulence.

Public health relevance
PROJECT NARRATIVE: JC Polyomavirus (JCPyV), a common human-specific pathogen, causes life-threatening brain diseases in immunologically compromised individuals. The Type I IFN axis is implicated in the onset of progressive multifocal leukoencephalopathy, a demyelinating neurodegenerative JCPyV disorder. This fellowship application will use a mouse model of polyomavirus CNS infection and novel recombinant viruses to investigate the neuropathologic and neuroprotective effects of the Type I IFN axis in infected neuroglia.